Optimizing Caffeine Therapy for Hypoxia in Preterm Neonates: A Randomized Trial Assessing Efficacy, Acute Kidney and Brain Injury, Safety, and Pharmacokinetics

PROJECT SUMMARY/ABSTRACT
Acute kidney injury (AKI), a serious complication in up to half of preterm neonates, independently increases
morbidity and mortality. Current detection methods, such as near-infrared spectroscopy (NIRS), can identify
kidney hypoxia—a precursor to AKI—earlier than traditional methods. However, effective therapies to prevent or
treat AKI in this vulnerable population remain elusive. Intriguingly, non-randomized studies suggest that caffeine,
a common medication in neonatal care, may lower AKI risk. Yet, rigorous investigations, particularly randomized
trials focused on AKI prevention, are lacking since the landmark Caffeine Therapy for Apnea of Prematurity trial.
Our long-term goal is to conduct a multicenter clinical trial to test the hypothesis that treatment of kidney hypoxia
with caffeine will reduce rates of AKI and improve two-year-old kidney outcomes.
“Optimizing Caffeine Therapy for Hypoxia in Preterm Neonates: A Randomized Trial Assessing
Efficacy, Acute Kidney and Brain Injury, Safety, and Pharmacokinetics” is a five-year R01 that responds
specifically to PAR-23-130: Translational Research in Maternal and Pediatric Pharmacology and Therapeutics.
Our research team has developed the necessary protocols and tools using NIRS to measure kidney and
cerebral oxygenation in preterm neonates. We have found significant associations between improvements in
kidney oxygenation after daily maintenance doses of caffeine in preterm neonates with kidney hypoxia. We
propose to investigate if an additional bolus dose of caffeine (either 10 mg/kg or 20 mg/kg) is more effective
than placebo in treating kidney hypoxia in preterm neonates <30 weeks’ gestation with at least 30 minutes of
kidney hypoxia (oxygenation <50%) in a randomized clinical trial. We aim to investigate the immediate and
short-term kidney (Aim 1) and brain outcomes (Aim 2) and to develop a pharmacokinetic model of kidney
hypoxia and caffeine levels (Aim 3).
Our research stands out for its innovative approach: using changes in kidney oxygenation, measured by NIRS,
as the primary outcome to promptly assess the efficacy of our proposed intervention. The research holds
significant potential; should the intervention prove effective, it paves the way for a large-scale, multi-center trial
aimed at investigating caffeine's role in preventing and reducing the incidence of AKI, as well as improving kidney
outcomes over a two-year period. Our team, with its robust pilot data and dedicated focus on neonatal kidney
research, is ideally suited to fulfill the objectives of this award.

Public health relevance
PROJECT NARRATIVE This project investigates whether caffeine can increase low kidney oxygen levels in premature infants while maintaining normal brain oxygen levels. We aim to assess the safety of various caffeine doses and their impact on short-term kidney and brain outcomes. Additionally, we will analyze urinary markers to detect changes in kidney and brain injury.